IDENTIFICATION OF FAMILIAL PHEOCHROMOCYTOMA OR VON HIPPEL LINDAU SYNDROME

The hypothesis to be tested in this study is that prospective investigation of families with an apparent excess of pheochromocytoma will allow earlier detection, syndrome delineation and improved outcome. Pheochromocytoma is a neoplasm of the adrenal medulla that is usually benign, sporad and unilateral, and such cases are not the subject of this protocol. Pheochromocytoma is occasionally one manifestation of inherited autosomal dominant endocrine/neurologic disorders. These include, but are not limited to MEN-IIa, MEN-IIb, Von Hippel-Lindau disease (VHL), and neurofibromatosis. The study, therefore, screens family members of probands for multiple endocrinopathies.